DATRI 020 EFFECT OF ACYCLOVIR FOR HERPES SIMPLEX VIRUS ON BLOOD HIV VIRAL LOAD

The purpose of this pilot study is to characterize the change in plasma HIV RNA levels and other measures of HIV burden during and after a course of acyclovir treatment for acute Herpes Simplex Virus (HSV) infection. A secondary objective is to charaterize the effect of acyclovir on T cell activation and cytokine production during and after the course of acyclovir treatment and to determine the relationship between changes in these parameters and changes in HIV burden.